A Novel Process Safeguards Genome Integrity In The Mammalian Germ Line-Administrative Supplement to Support Undergraduate Summer Research Experiences

PROJECT SUMMARY
Simple purine–pyrimidine (Pu/Py) repeats (PPRs) are known to form the left-handed, fragile Z-DNA structure.
Such repeats are also known to be highly mutagenic, inducing large chromosomal deletions and rearrangements
in the cells of higher organisms. The mutagenic effects of Z-DNA would be the most detrimental to a species if
breaks occurred uncontrollably in the germ line and mutations occurring at unrepaired breaks were passed on
to the next generation. We discovered a novel biological process in the mammalian germ line that controls
Z-DNA structure at PPRs. Using the Zbtb43 mutant mouse genetic model and our transgenic mouse line
that allows us to isolate germ cells, we found that a previously uncharacterized DNA binding protein,
ZBTB43 remodels Z-DNA structure and protects from double-strand breaks in fetal male germ cells in
vivo. By biochemical assays we found that ZBTB43 binds to PPR-rich DNA sites in the genome in vitro.
ZBTB43 binding sites form Z-DNA and cause large genomic rearrangements in mammalian cells. By in vivo
epigenome mapping we detected Z-DNA in mutant germ cells at the locations where ZBTB43 binding
occurs in wild-type prospermatogonia. We hypothesize, therefore, that ZBTB43 safeguards genome
integrity in the germ line by binding and eliminating Z-DNA at PPRs. In addition, we found that by eliminating
Z-DNA, ZBTB43 promotes de novo methylation at PPRs during the time of global epigenetic remodeling. We
propose to pursue the following aims, using a combination of genetic, cell biology, biochemistry, and
epigenomic approaches. In Aim I, we will test the working hypothesis that ZBTB43 eliminates Z-DNA structure
in vivo by directly binding to PPRs in fetal male germ cells. We will determine 1) the spatial and temporal
changes of the Z-DNA structure in fetal male germ cells in the presence or absence of ZBTB43 protein in
vivo; 2) the dependence of the Z-DNA remodeling process on the direct binding of ZBTB43 to the Z-DNA
structure in vivo; and 3) the molecular requirements of ZBTB43 action on Z-DNA. In Aim 2, we will test the
working hypothesis that ZBTB43 facilitates de novo DNA methylation in prospermatogonia indirectly by
eliminating Z-DNA, thus revealing the sequences as substrates for de novo methyltransferases. We will map
DNA methylation in the presence and absence of ZBTB43 during the epigenome remodeling process in fetal
male germ cells. We will test whether de novo DNMTs methylate Z-DNA substrates in vitro. We will test
whether ZBTB43 affects nucleosome occupancy at PPRs. In Aim 3, we will test the hypothesis that Z-DNA is
mutagenic in the germ line and that ZBTB43 has evolved to manage that burden. We will map double-
strand breaks in mutant fetal germ cells, test the anti-mutagenic effect of ZBTB43 in cell culture, and search
for genomic rearrangements in sperm of Zbtb43 mutant males. By the end of the grant period, we will have
identified and characterized the first example of how a DNA binding protein protects genome integrity and
targets de novo DNA methylation by controlling Z-DNA structure in the mammalian germ line.

Public health relevance
PROJECT NARRATIVE It is not known how the species safeguards its genome from the mutagenic insults of the fragile left-handed Z- DNA structure, which can form in the cells at simple repeat sequences. We discovered a natural biological process that eliminates Z-DNA structure in mammalian germ cells, and a novel DNA-binding protein that carries out this function, positing this protein as the guardian of the germ line. We will employ a combination of genetics, in vivo epigenome mapping, and in vitro biochemistry approaches to determine the molecular mechanisms and significance of managing Z-DNA structure in the germ line.